Administrative Core

SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The Administrative Core will be responsible for the proper and smooth functioning of administrative,
regulatory, and financial needs of the program. It will serve all three projects and three cores over all 5 years of
the program.
The goals of Administrative Core are to:
 maximize efficient use of investigator time by tracking expenses and supplies;
 facilitate annual submission of scientific and financial reports and other correspondence to the NHLBI
regarding the program project;
 arrange repair of equipment, maintain service contracts, and ensure compliance with institutional
requirements; and
 organize meetings of the executive committee, the entire program project scientific group, and the Internal
and External Advisory Boards;
Dr. Hussain will be in charge of administrative functions. The Administrative Core will take the lead in
handling all post-award issues and the budgetary components of the program project, including distribution and
management of funds and service contracts. The Administrative Core will maintain well-organized and
efficient administrative control of the program project. Its involvement in hiring will include interacting with the
Department of Human Resources, and filing and follow-up of all visa applications with the Office of
Immigration. It will take the lead in submitting and maintaining all institutional requirements such as, but not
limited to: filing and informing investigators of the need to update conflicts of interest training and filings, animal
care and use protocols, institutional biosafety and environmental health guidelines, and complying with all the
institutional regulations. The Administrative Core will be responsible for assisting the project and core leaders
in all matters related to submission of progress reports, document preparation, and correspondence among the
project leaders, core leaders, collaborators, and subcontracts. The Administrative Core will organize
meetings and retreats to facilitate interactions among program project personnel and with Internal and External
Advisory Boards.